Establishing PREMISE: A PrEP Epidemiology, Modeling, and Surveillance System

Abstract
To reach Ending the Epidemic (ETE) targets, we will need consistent national HIV pre-exposure prophylaxis
(PrEP) data to describe patterns of use, and to understand which programs and policies are effective at
facilitating PrEP uptake. Our team has used national PrEP prescription datasets that combine diverse sources
in order to better understand how PrEP is being brough to scale. National prescription datasets are robust and
capture a great deal of data. We propose to develop the PREMISE (PrEP Epidemiology, Modeling, and
Surveillance) group that will use national PrEP data, along with legal and policy coding, to inform the US HIV
epidemic response. Legal and program environments in which individuals initiate PrEP are highly
heterogeneous, yet evidence regarding which policies lead to improved outcomes is lacking. Our past work
demonstrated a substantial association between PrEP use and the presence of PrEP drug assistance
programs. ETE programs have expended considerable resources in HIV prevention promotion programming.
Natural experimental designs can provide evidence regarding PrEP uptake in light of such programs. Such
analyses require developing nuanced datasets of policies and programs. Our team has extensive experience
in both PrEP program and policy data collection, allowing for rigorous assessment. The study will conduct
analyses regarding the scope and equity of PrEP scaleup over time, and will perform analyses to explore the
impact of different locality-specific programs and policies on PrEP starts and PrEP equity. We will use modeling
and cost-effectiveness analyses to contextualize findings and facilitate dissemination

Public health relevance
Narrative To reach Ending the Epidemic (ETE) targets, we will need consistent national HIV pre-exposure prophylaxis (PrEP) data to describe patterns of use, and to understand which programs and policies are effective at facilitating PrEP uptake. We propose to build on our history of developing public PrEP data resources and innovative metrics of PrEP use in PREMISE (PrEP Epidemiology, Modeling, and Surveillance), a collaborative and interdisciplinary group that will use national PrEP data, along with legal and policy coding, to inform the US HIV epidemic response. The study will conduct analyses regarding the scope and equity of PrEP scaleup over time, and will perform analyses to explore the impact of different locality-specific programs and policies on PrEP starts and PrEP equity.